Evaluating the therapeutic potential of vagal CART circuitry for treating metabolic disease

ABSTRACT
Despite decades of research, effective therapies for obesity are lacking. Given the magnitude of the obesity
epidemic, there is a critical need for intervention strategies that effectively reduce body weight and maintain
weight loss. Nodose ganglia (NG) neurons of the vagus nerve that innervate the gut are a key component of the
nutrient sensing machinery that provides negative feedback to terminate a meal. Postprandial signals are sensed
by vagal afferent terminals in the gut and the information is relayed centrally to neurons of the nucleus tractus
solitarius (NTS). The neuropeptide cocaine and amphetamine regulated transcript (CART) expressed by NG
neurons is a primary molecular signal that controls caloric intake. In obesity, loss of vagal CART is sufficient to
increase food intake and body weight. Therefore, we hypothesize that in diet-induced obesity, restoring CART
expression in NG neurons will cause voluntary reduction in food intake and sustain body weight after weight loss
interventions. To evaluate the therapeutic potential of targeting CART and NG neurons innervating CART
(NGCART) we will study 1) how metabolic cues are integrated in NGCART neurons, 2) how this information is relayed
centrally, and 3) the impact of overexpressing CART in NG neurons on body weight. We apply powerful genetic
and molecular neuroscience tools to the vagus nerve for in vivo imaging, connectivity mapping, and targeted
overexpression in NGCART neurons. In aim 1, we propose to determine the metabolic signals that recruit NGCART
neurons by using a Cre-dependent viral tracer injected into the NG of CARTCre mice to map the projections and
terminals of NGCART neurons in the gut, and record the activation profile of these neurons in live animals by using
a genetically targeted calcium indicator. In aim 2, we will combine multisynaptic circuitry tracing with serial two
photon tomography to map NGCART neurons synaptic circuitry through the brain. In aim 3, we will use a cre-
dependent CART overexpression virus to restore CART expression in NGCART neurons of CARTCre mice and
determine the impact on feeding and body weight in diet induced obesity. These studies will elaborate on
previous work by identifying a molecular and cellular target that can provide the foundation for developing
peripheral treatments for obesity.

Public health relevance
NARRATIVE There is an urgent need for effective therapies to treat the obesity epidemic. In previous work we have found that a population of peripheral neurons, important in the control of food intake, lose their ability to tell the brain to stop eating after prolonged ingestion of palatable high-fat high-sugar diets. We will study how these neurons process nutrient information, which parts of the brain they signal to, and whether restoring the molecular signal released from these neurons to the brain could be effective in promoting weight loss and prevent weight regain after dieting.